MECHANISMS OF CYCLOSPORIN NEPHROTOXICITY

The project objectives include: to determine if calcium channel blockers ameliorate the nephrotoxic effects of cyclosporine; to measure multiple markers of renal hemodynamics; to draw an inference concerning the mechanism of cyclosporine nephrotoxicity based on recipient response to calcium channel blockers.